Inflammatory changes and glymphatic dysfunction in carbon monoxide neuropathology

ABSTRACT
This project is to elucidate the role of inflammation and perturbations of the brain glial-based
lymphatic (glymphatic) pathway in carbon monoxide (CO)-induced brain injuries. Based on
preliminary data we hypothesize that astrocyte-derived microparticles (MPs) expressing
thrombospindin-1 play a causal role in CO-induced neuropathology that includes glymphatic
dysfunction. Further, once these MPs are liberated to the bloodstream they activate circulating
neutrophils that sequester along the neurovasculature to exacerbate inflammation, leading to
functional neurological deficits. Specific aims are: (1) Assess glymphatic function in response to
CO in mice by MRI and fluorescence microscopy; (2) Identify the role of glymphatic outflow to
CO-neuropathology in mice; (3) Determine the relationship of neuroinflammation and glymphatic
dysfunction to functional deficits; (4) Evaluate associations of morbidity in CO poisoned patients
with MPs elevations and intra-particle pro-inflammatory agents.

Public health relevance
NARRATIVE This project will examine the role of circulating microparticles and glymphatic functional changes seen associated with carbon monoxide neuropathology. Studies involve a murine model and a survey of blood samples obtained from patients who are suffering acute carbon monoxide poisoning.